Genetic dissection of trait variation between long-diverged mouse species

PROJECT SUMMARY/ABSTRACT
Over the four billion years that life has evolved on this planet, organisms have acquired amazing phenotypes.
Some, like lions' manes and butterflies' wings, capture our attention by their sheer beauty. Others get us
excited in a very different way—their relevance to biomedicine. Ecologists have catalogued remarkable
disease and stress resistance traits in the plant and animal worlds, which have arisen to solve problems similar
to those in human patients. We'd love to know the molecular basis of these natural resistance phenotypes, so
that we can design drugs to mimic them in the biomedical context. However, most often, we know about a
given trait because it is a defining feature of its respective species, acquired long ago to adapt to a unique
niche. Now, millions of years later, the species usually has lost the ability to interbreed with relatives in other
environments. And this reproductive isolation is a death knell for existing tools to map genotype to phenotype.
The latter, which fill the pages of the modern genetics literature, rely on big panels of recombinant progeny
from matings between distinct parents. These tools are no use in the study of species that can't mate to form
progeny in the first place.
We have developed a new strategy to break through this roadblock, and map the genetic basis of trait variation
between long-diverged species. Our approach starts with a viable, but sterile, interspecific hybrid. In this
hybrid, at a given gene, we introduce mutations to disrupt each of the two alleles in turn from the two species
parents. These hemizygote mutants are identical with respect to background, except that at the target gene,
each strain expresses a wild-type allele from only one of the parents. As such, if the hemizygotes differ with
respect to a trait of interest, we infer that it must be because of functional allelic variation at the manipulated
site. We have pioneered a genome-scale pipeline for this so-called reciprocal hemizygosity test, which we call
RH-seq, using yeast as proof of concept. In the current proposal we describe experiments to port RH-seq to
mammalian cells. We focus on a little-studied mouse species, M. castaneus, which can regrow axons of the
central nervous system after injury. The genes we find in this pioneering study will serve as a springboard for
drug design for stroke and brain trauma patients. And our metazoan RH-seq approach will pave the way for the
genetic dissection of trait variation between species across Eukarya.

Public health relevance
PROJECT NARRATIVE Dissecting the molecular basis of naturally occurring trait variation is one of the central goals of modern genetics, but existing methods for this purpose can't be applied to reproductively isolated individuals. We have developed a new method to dissect trait variation between long-diverged, incompatible species; here we propose to apply our approach to a remarkable axonal regeneration phenotype in a little-studied mouse species, Mus castaneus. Our work will reveal the genes that underlie resistance to stroke and traumatic brain injury in M. castaneus, and will set the stage for dissections of species differences across Eukarya.